Transvenous Optoacoustic-Ultrasound Guided Cold Laser Wire for Crossing Coronary Chronic Total Occlusion

ABSTRACT
Coronary chronic total occlusions (CTOs) are atherosclerotic plaques comprised of hard fibro-calcific material
that restrict luminal cross-section by 100% resulting in complete stoppage of blood flow in the affected artery for
at least three months. CTO symptoms include shortness of breath with chronic fatigue and chest pain. The
three primary CTO treatment regimens are medical therapy (MT), coronary artery bypass graft (CABG) and
percutaneous coronary interventions (PCI). MT can reduce symptoms such as chest pain but fail to address the
underlying disease mechanisms. CABG does provide marked improvements in both patient morbidity and
mortality, however, this open-heart surgical intervention is highly invasive, traumatic, expensive and has a limited
lifetime. Because most CABG grafts utilize re-purposed veins, 50% become occluded within ten years after
bypass surgery. PCI procedures are provided over a 24-hour hospital stay, have one-two days of recovery time
and cost approximately one-fourth of CABG yet are currently administered to only 10% of CTO patients. In the
most common PCI procedure, subintimal crossing, a mechanical wire is advanced past the CTO inside the vessel
wall. Few interventionalists practice subintimal crossing because the procedure is difficult, risky and associated
with higher MACE, restenosis, acute MI and death. Although many intravascular devices have been introduced
to perform PCI true-lumen CTO crossing, all have failed in the coronary arteries. Failure of these previous
devices is due to at least one of three causes: 1) large-diameter catheters that are too rigid with poor steerability;
2) non-specific injury to the vessel wall resulting from CTO cutting; and 3) absence of a navigational guidance
system based on real-time imaging of the catheter tip relative to the arterial wall. An optoacoustic (OA) and
ultrasound (US) image-guided cold laser wire (CLW) is proposed that provides controlled cutting that will allow
any interventional cardiologist to provide patients safe and efficacious PCI true-lumen CTO crossing.
Development of the transvenous OA/US image-guided CLW will be accomplished by completing three specific
aims: Aim 1: Develop an Optoacoustic (OA)/Ultrasound (US) Transvenous Image-Guided Cold Laser
Wire; Aim 2: Test CLW True-Lumen PCI CTO Crossing in ex vivo Human CABG Hearts; Aim 3: Test CLW
True-Lumen PCI Crossing of Calcified CTOs in in vivo Animal Models. Successful completion of the
proposed research and development program will introduce a true-lumen PCI CTO crossing procedure that
when followed by stenting can establish a superior and new treatment paradigm for interventional cardiology
and can impact other surgical disciplines.

Public health relevance
PROJECT NARRATIVE Chronic total occlusions (CTOs) are lesions comprised of hard fibro-calcific material that completely stop blood flow in a coronary artery and are traditionally treated with either medical therapy or bypass surgery. Percutaneous Coronary Interventional (PCI) procedures can be performed, but are technically difficult, and often pass the CTO by traversing inside the vessel wall, leading to higher complication rates. We are developing and testing an optoacoustic- ultrasound image-guided cold-laser-wire which can provide any interventional cardiologist a much simplified single-operator approach to stay true-lumen while traversing a coronary CTO and reducing rate of patient complications.